DNA Transistors for Cellular Programming

PROJECT SUMMARY/ABSTRACT
The "DNA Transistors for Cellular Programming" project aims to revolutionize synthetic biology
by developing tools that enable precise, modular, and multiplexed control over cellular functions.
Utilizing DNA-binding domains from nuclease technologies, such as TALENs and zinc finger
nucleases, our research focuses on creating DNA-based transistors capable of operating both
extracellularly and intracellularly. This dual functionality permits unprecedented manipulation of
cellular activities through specific DNA sequences, whether inherently present or introduced by
researchers.
Our project is structured around two primary goals: the development of Extracellular DNA
Transistors for Signal Interpretation and Intracellular DNA Transistors to Regulate Cell Function.
The first goal aims to engineer synthetic membrane receptors that respond to specific DNA
sequences, allowing precise control of cellular responses to both introduced and naturally
occurring cell-free DNA. The second goal concentrates on internally manipulating cellular
processes by using targeted DNA sequences to regulate the activity of enzymes and proteins,
offering a highly versatile and programmable approach to cellular control.
This groundbreaking approach not only enhances our understanding of cellular dynamics but also
paves the way for innovative therapeutic interventions. By offering a method to program cells with
high specificity and minimal off-target effects, our project holds the potential for significant
advances in disease treatment and tissue engineering. If successful, this research could establish
new benchmarks in the control and programming of cellular functions, echoing the transformative
impact of electronic transistors in computing.

Public health relevance
PROJECT NARRATIVE The "DNA Transistors for Cellular Programming" project represents a transformative advancement in synthetic biology, enabling precise, modular control over cellular functions through DNA-based transistors. These innovative tools can activate specific cellular processes by recognizing DNA sequences, providing a platform for both fundamental research and therapeutic applications. This technology promises to significantly enhance the precision of cellular engineering, opening new possibilities for treating diseases and understanding complex biological systems.